Admin-Core-001

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Berkeley Population Center’s general goal is to reduce the administrative burden on its researchers and
maximize the scientific time spent on successful progress of their research agenda. The Administrative Core is
the central organizational unit that coordinates across the BPC staff and the executive leadership team, the
Development Core, faculty affiliates, computing services, and collaborating partners across campus. The
Administrative Core is comprised of two sub-cores: the Administrative Services sub-core, for the Center’s
operations and logistics, and the Data and Computing sub-core, which ensures that, with high-quality and
responsive services, the BPC faculty affiliates have access to all available data and computing resources. The
overarching aims of this Core are to effectively manage all Center activities; to foster and grow the Center’s
research environment; to communicate with the community and disseminate research; and to provide modern,
advanced data and computing infrastructure for our affiliates.